Nuclear-Mitochondrial Mismatch in Mitochondrial Function and Disease

PROJECT SUMMARY/ABSTRACT
Mitochondria are critical organelles that integrate many aspects of cellular function, most notably the generation
of the vast majority of cellular energy via the oxidative phosphorylation (OXPHOS) pathway. Mitochondria require
the coordination of their own small genome of 37 genes with more than 1,000 nuclear-encoded genes in order
to function properly, resulting in a close match between nuclear and mitochondrial-encoded genes. Mitochondrial
diseases, among the most common genetic disorders in humans, are the result of mutations causing a mismatch
between these nuclear and mitochondrial-encoded genes that lead to mitochondrial dysfunction. Despite the
importance of mitochondria in the cell and the impact of mitochondrial dysfunction on human health, our
understanding of the specific genetic underpinnings of mitochondrial dysfunction remains limited. The proposed
research aims to address these knowledge gaps by utilizing a highly tractable genetic model system, Nasonia
wasps, to determine how mutations that result in a nuclear-mitochondrial genetic mismatch negatively impact
mitochondrial function and organismal health. These wasps have simple genetics, haploid males and diploid
females, that make them ideal for determining the genetic basis of mitochondrial dysfunction. We propose to
analyze mitochondrial function using assays that are used to diagnose mitochondrial disease in humans,
specifically the function of the individual enzymes of the OXPHOS pathway as well as overall mitochondrial
respiration rate in mitochondria isolated from interspecific hybrid strains of these wasps. Specific Aim 1 will focus
on analyzing hybrids that have previously been shown to suffer from ~98% male juvenile mortality when they
have a nuclear allele at a single locus that is mismatched with their mitochondria, as well as analyzing hybrids
produced using a strain of wasps that has been shown to significantly rescue this mortality due to having the
nuclear allele that matches the mitochondria. Using these two hybrid types, this Aim will measure the function of
mitochondria from haploid male wasp larvae before they die in order to directly test the mismatched allele’s
impact on mitochondrial function, as well as in diploid adult females that have been shown to suffer less mortality,
mirroring the recessive nature of most human mitochondrial diseases. Specific Aim 2 will focus on identifying
additional loci underlying hybrid mortality associated with mitochondrial mismatch using genome-wide
sequencing of very large pools of surviving adults. Each mitochondrially-mismatched loci will then be isolated in
a separate wasp strain with an otherwise mitochondria-matching nuclear genome via marker-assisted
introgression, and these strains will be assayed for mortality and mitochondrial function to determine the impact
of each mismatched locus on mitochondrial and organismal health. This project will provide valuable insights
into the specific impacts of mutations on mitochondrial function as well as our basic understanding of the genetic
underpinnings of mitochondrial function in general. Moreover, this project will provide strong research
experiences for students engaged in it while strengthening the research environment for future students.

Public health relevance
PROJECT NARRATIVE Mitochondrial are crucial components of our cells that provide the majority of the energy that our bodies use, and they rely on the tight coordination of over a thousand genes to perform these functions. Mitochondrial diseases are among the most common genetic disorders in humans, and are the result of mutations in these coordinated genes that disrupt the normal function of mitochondria. The proposed research aims to address the impact of mutations in these genes on mitochondrial function using an animal model system, which will deepen our understanding of the genetic basis of mitochondrial function as well as mitochondrial disease.